Pharmaceutical Research Center Shared Resource

PROJECT SUMMARY/ABSTRACT
The Pharmaceutical Research Center (PRC) operates within the University of Wisconsin Health System (UW
Health) and is responsible for the safe and ethical provision of investigational study medications to research
subjects enrolled in all clinical drug trials within our hospitals and clinics, including those of The University of
Wisconsin Carbone Cancer Center (UWCCC). The mission of the PRC is to ensure that drug research
protocols proceed optimally through established medication use systems and in accordance with all federal,
state, institutional, and sponsor regulations governing clinical research. PRC services enhance regulatory rigor
and subject safety while facilitating the conduct of clinical drug research within our academic medical center.
For each clinical drug trial, PRC establishes study drug handling, distribution, preparation, and destruction
procedures; develops a protocol specific workflow; creates an investigational drug monograph(s) for health
care providers; educates health care staff regarding protocol procedures; creates the physician orders set;
manages drug inventory and accountability; prepares drugs and/or monitors drug preparation; monitors drug
expiration and retest dates; provides quality assurance audits; and reviews all protocol amendments. In
addition, PRC provides services that are specifically tailored to the unique needs of UWCCC investigators. For
example, PRC manages trials involving gene therapy and hazardous oncology drugs; provides accurate
response to drug interaction inquiries from investigators and care providers; and verifies authorized prescriber
status in accordance with NCI requirements. During the current CCSG funding cycle, PRC has enabled
UWCCC investigators to implement 170 peer-reviewed clinical drug trials and has provided study drug
oversight for an average of 200 cancer focused clinical trials each year. PRC strives to refine, enhance and/or
expand our services to meet the evolving needs of the UWCCC research faculty and our research subjects,
while operating in rapidly changing healthcare and regulatory environments. Our specific aims are to: 1)
provide detailed protocol review and feasibility assessment of each UWCCC protocol; 2) ensure all UWCCC
study protocols comply with Good Clinical Practice (GCP) standards; 3) provide services essential to the
advancement of clinical cancer research; and 4) facilitate clinical drug research within UW Health satellite
pharmacies that extend clinical cancer research across our catchment area. Base funding from the CCSG
allows PRC leaders to serve as members of the UWCCC scientific leadership team to ensure PRC is well
positioned to meet the evolving needs of UWCCC investigators and thereby enhance the ability of our
members to enroll patients onto investigator initiated clinical studies that ultimately will improve outcomes for
our patients and society.